P20 Exploratory Center for Precision Health in Diverse Populations

Abstract/Project Summary
Precision Health Technologies Core
The proposed P20 Exploratory Center for Precision Health in Diverse Populations will utilize a socio-ecological
and precision health model to develop nurse scientists and interdisciplinary teams dedicated to advancing
research in Metabolic Syndrome (MetS) and related multiple chronic conditions (MCC), their biological
mechanisms, modifiable risk factors, and the best interventions to reduce or eliminate MCC burden. Precision
health research involves using and integrating multiple data types and technologies in order to address
biological, behavioral and environmental mechanisms underlying conditions at the individual to mesosytem
levels (i.e., interaction between the individual and direct family and social networks). Precision health research
in MetS and related MCC will incorporate mHealth, sensors, clinical, and omics data in order to achieve a full
picture of the conditions and relevant self-management, treatment and prevention. Applying precision health
technologies to research in MetS requires experience, expertise and use of validated technologies to support
rigorous, ethically sound research. To facilitate the overall Center aims, the aims of the precision health
technologies core are as follows: 1) Develop a sustainable infrastructure to support researchers internal and
external to the proposed center to integrate PHT into their chronic disease research; and 2) Support the
advancement of nursing science in precision health and MetS through collaborative, interdisciplinary research
incorporating PHT. Components and activities of the core to address these aims include precision health
research consultations, precision health technologies research procedures and orientation, technology
acquisition and inventory, and precision health technologies facilities. To maximize its impact, this core will be
a sustainable, expert-led resource for precision health research in MetS and related MCC that benefits center
investigators, NYU College of Nursing researchers, and the greater NYU/NYC research community. This core
will provide a model for other research and nursing institutions as they develop infrastructure to extend
capacity in nursing precision health research.